High-definition infrared micro-spectroscopic imaging of biomaterials

We are developing new approaches to quantitative, label-free histological examination of tissues by infrared micro-spectroscopy. In this technique, an infrared spectrometer with a 2D detector array is attached to a microscope. It simultaneously measures infrared absorption spectra at 16,384 micron-size spots in a tissue section. Chemical composition, orientation and interactions of chemical groups are determined within each spot from unique spectral fingerprints of chemical compounds and plotted as 2D-images. To date, applications of this technique to research and diagnostics have been limited to dehydrated tissues because water strongly absorbs infrared light, resulting in optical interference artifacts. However, dehydration distorts biomolecular and tissue structure, smears out spectroscopic fingerprints, and degrades chemical and spectral resolution. To overcome this limitation, we designed and constructed an infrared chamber with thermo-mechanical stabilization, which allows keeping tissues in solution at desired temperature. By reducing the interference artifacts, we increased spectral reproducibility and chemical resolution by two orders of magnitude compared to commercial designs. Versatile solvent control and increased spectral accuracy of the new chamber allow qualitatively new experimental approaches. For example, with this technique we distinguish collagen from other proteins, resolve different glycosaminoglycans (GAG) and even quantify the extent of GAG sulfation in cartilage. Recently, we collected a spectral library of well-purified and characterized components of connective tissues, which we measured with significantly improved spectro-chemical resolution. We also developed a new approach to quantitative mapping of collagen orientation in tissue sections by polarized infrared hyperspectral imaging. To correlate tissue composition with biochemical processes, we bridged high-definition microspectroscopic imaging with analytical autoradiographic imaging with micrometer spatial resolution. In addition, we designed a new thermo-mechanically stabilized, flow-through chamber for high-definition Raman microspectroscopy, allowing a simultaneous additional characterization of bone specimens with Raman, polarized and fluorescence microscopies. During the last year, we adapted in vivo dynamic labeling of bone formation surfaces with fluorescence dyes which allows to demarcate bone regions formed at given time points and to perform high-definition Raman microspectroscopy on the same samples. We further extended high-definition spectral library of model connective tissue compounds and continued developing computer analysis of the spectra, increasing chemical resolution and accuracy. We are utilizing these techniques for characterization of collagen matrix organization in Osteogenesis Imperfecta, chondrodysplasias, bone tumors and other connective tissues pathologies. Specifically, we studied a knock-in mouse model of Diastrophic Dysplasia (DTD) caused by mutations in SLC26A2 sulfate/chloride antiporter. These mutations result in deficient sulfate uptake by chondrocytes, leading to undersulfation of proteoglycan GAG chains crucial for cartilage development and integrity. Like other inborn chondrodysplasias, DTD has delayed skeletal development, but exhibits an unusual progression. The undersulfation is normalized with age. Nonetheless, the articular cartilage degrades with age. To understand the mechanism of the progressive cartilage degradation, we collected 5-micron-resolution, quantitative images of distributions of major extra-cellular matrix components across femur head cartilage and growth plate in newborn DTD and wild type (WT) mice. We showed that in DTD mice, GAG sulfation was low compared to WT in the articular and proliferative zones but almost normal in the resting zone. In DTD mice, polarized infrared hyperspectral imaging revealed disruption of a dense layer of tangentially oriented collagen fibrils at the articular surface. The tangential collagen layer normally protects cartilage from frictional damage and synovial enzymes. Its disruption may cause articular proteoglycan depletion, a hallmark of early osteoarthritis, which we observed at birth and which further progresses with age despite the normalization of GAG sulfation. Collagen orientation in DTD mice was also disrupted throughout the femur head and growth plate. The disruption severity correlated with the extent of GAG undersulfation but not with densities of collagen, noncollagenous proteins and GAG chains, suggesting that GAG sulfation might be crucial for synthesis of the oriented matrix by cells. We used quantitative microradiography to study 35S-sulfate incorporation into cartilage explants, to show that variability of undersulfation across different cartilage regions in DTD was associated with faster chondroitin synthesis rate in the articular and proliferative zones. This observation explained the undersulfation normalization with age, when the cartilage growth slows down, and provided basis for developing a kinetic model for the regulation of GAG sulfation and new potential targets for DTD treatment. We investigated effects of stem cell transplantation on bone quality in the Brittle mouse model of Osteogenesis Imperfecta. Using fluorescence and polarized-light microscopy, we distinguished matrix produced by host cells and green-fluorescent-protein-labeled donor cells within different types of bone (woven, lamellar and fine-fibred) in femoral cortex. Using Raman microspectroscopy, we found that matrix mineralization heterogeneity near donor cells was lower within each material type, suggesting that better organization of matrix made by the donor cells may contribute to the amelioration of bone mechanical properties observed in the treated mice. We studied endocrine bone tumors caused by cyclic AMP signaling disruption in mice with different combinations of Prkar1a+/- deletions with Prkaca+/-, Prkar2a+/-, or Prkar2b+/- deletions in protein kinase A. Using polarized-light microscopy, Raman microspectroscopy, and dynamic bone labeling, we found that tumor formation in adult Prkar1a+/-/Prkaca+/- mice causes periosteal deposition of immature cortical bone, in which collagen and mineral organizations are intermediate between those of woven and lamellar bone. We found partial compensation of Prkar1a+/- deletion effects on local maturation of bone material, matrix mineralization and collagen organization by additional deletions of Prkar2a+/- or Prkar2b+/-. We also assisted NIBIB scientists in utilizing our technology for demonstrating penetration of functionalized carbon nanotubes inside cancer cells that overexpress hylauronate receptors, validating this approach to intracellular delivery of anticancer agents. We developed a method of non-destructive quantification of collagen content in cell cultures using high-definition Raman microspectroscopy. We applied this method to human fibroblast cell cultures from recessive osteogenesis imperfecta caused by FKBP10-null mutations. We found reduced deposition of collagen in the extracellular matrix despite synthesis of normal collagen quantities by these cells, which may contribute to brittleness of patients bones. During the last year, we showed that collagen deposition in fibroblast cultures of patients with FKBP-10 mutation causing Kuskokwim syndrome does not correlate with the disease severity. We also showed that osteoblasts from ppib-/- mouse deposit 1/3 of the normal amount of collagen. We showed that osteoblast differentiation and tumor growth in R1a+/-/Ca+/- mice was affected by Celecoxib treatment. We showed that Celecoxib slows the growth of caudal vertebrae tumors and improves organization and mineralization of cortical bones covering the tumors.